Molecular Mechanisms Underlying Adaptor-Mediated Integrin Signaling in a Species-Specific Manner

PROJECT SUMMARY/ABSTRACT
My laboratory is interested in understanding the molecular mechanisms underlying cell adhesion and
motility mediated by integrins and related small GTPases, and applying these findings to the development of
new class of inhibitors for potential therapeutic benefits. Integrins are cell adhesion molecules that transduce
signals across the plasma membrane in both directions. Thrombotic disorders, cardiovascular diseases, T cell
proliferation defects, and many autoimmune diseases have been linked to the misregulation of integrin
expression and its activity. The major gaps in the field of integrin and related signaling pathways include
inaccurate molecular models of signaling events mediated by the integrin activator, a lack of understanding to
the regulation of different integrin species, unknown mechanism underlying the peculiar dual GTPase specificity
of their effector protein, and a lack of inhibitors targeting intracellular adaptors.
We have obtained substantial preliminary data to bridge this gaps. The main goals of the lab for the next
five years are to investigate the signaling mechanisms of the adaptors and integrins, focusing on the connection
of isoforms and posttranslational modifications with specific integrin species and related GTPases, and to
develop a new class of adaptor protein inhibitors to control integrin functions. The proposed studies include both
basic research and translational research, which reflect an ever-expanding scope of the research in our research
program. Our vigorous efforts would undoubtedly support us to achieve the overall goal of conquering integrin
related diseases by more effective therapeutic interventions.

Public health relevance
PROJECT NARRATIVE/RELEVANCE TO PUBLIC HEALTH Integrin dysfunction has been linked to severe health conditions such as thrombotic disorders, cardiovascular diseases, and inflammatory diseases. We proposed to elucidate regulatory mechanisms in integrin signaling in a species-specific manner and to develop peptidomimetic inhibitors that target the activator molecule of integrin. Our study will offer new insights into the integrin signaling mechanisms and a new class of integrin inhibitors by suppressing the activity of an intracellular integrin activator.